Identification and targeting of pathways separating healthy stem cell aging from malignant transformation

ABSTRACT
Myelodysplastic syndrome (MDS) and acute myeloid leukemia (AML) are generally incurable hematologic
malignancies, originating from aberrant hematopoietic stem and multipotent progenitor cells (HSPC). These
diseases occur mainly in the elderly and are preceded by an often-unrecognized precancerous phase, which
can last for years and is hallmarked by a progressively changing HSPC compartment. These molecularly and
functionally diverging stem cells, harbor a higher propensity to undergo malignant transformation. Mechanisms
that separate the healthy aging process from cancer evolution are incompletely resolved. This gap in our
knowledge poses a significant challenge for the development of curative therapies for myeloid malignancies for
which overall cure rates have remained below 30% over the last decades.
Our study will investigate the role of chaperone-mediated autophagy (CMA), a highly selective subtype of
autophagy, which we recently demonstrated to confer key roles in stress mitigation in and metabolic control of
HSPC. Contrary to macroautophagy, CMA specifically degrades proteins containing defined recognition motifs
(“KFERQ”, and variants), and maintains integrity and proper function of many cell types during chronic stress
and aging. CMA declines in and critically contributes to several age-associated pathologies, yet its role in
leukemogenesis and cancer stem cell evolution is unknown. Using new genetic mouse models, we have
obtained exciting preliminary data strongly suggesting that loss of CMA drives expansion of HSPC bearing gene
lesions found in clonal hematopoiesis of indeterminate potential (CHIP); yet upon malignant transformation, CMA
is critically needed in and likely selected for in LSC. For this study, we hypothesize that CMA enables LSC
maintenance through governing metabolic adaptation to amino acid starvation, licensing increase of fatty acid
production through upregulation of coenzyme A synthesis from lysosomal cysteine.
We will utilize a complementary model set consisting of genetic mouse models, human cell lines and primary
patient-derived cells for the study of (i) CMA activation patterns in CHIP-HSPC and LSC (leveraging a CMA
reporter mouse and lentiviral CMA biosensors for primary human cells), (ii) molecular and (iii) functional
consequences of CMA inactivation and stimulation.
Our study will provide new insights into a molecular mechanism declining during aging and predisposing adult
tissue-specific stem cells to malignant transformation, which will have important implications for the development
of new therapeutic strategies for targeting autophagy in myeloid malignancies, and possibly other stem cell-
derived cancers.

Public health relevance
NARRATIVE Several blood cancers arise during aging (including myelodysplastic syndrome (MDS) and acute myeloid leukemia (AML)) in a process that progressively alters adult blood-forming stem cells. Molecular alterations that separate healthy aged stem cells from stem cells developing cancer, are vastly unknown, but hold the key for curative therapies. We will be the first to investigate the contribution of a highly specific form of autophagy (“self- eating”), which is the cells’ waste and recycling system, to blood cancer formation and therapy resistance. Our study may provide a new therapeutic avenue for patients with MDS and AML, and potentially a paradigm for other currently incurable stem cell-derived cancers.